Predicting individual disease risk for individuals harboring monogenic risk alleles with deep learning

Project Summary/Abstract
Translating genetic information into clinical and public health practice requires a detailed understanding of
how genetics influence disease risk. While many monogenic disease risk alleles have been identified, the true
level of risk these alleles confer remains unknown for many alleles. Many people with disease risk alleles never
develop disease, especially for rare diseases. This disconnect between genetic risk and actual pathogenesis
limits the clinical usefulness of pure genetic information. To implement precision medicine requires new
methods and techniques that integrate non-genetic factors with genetic risk to produce a complete picture of
individual risk. In this proposal, we propose to develop new methods to predict disease risk among individuals
who harbor rare monogenic risk alleles, refining the accuracy of genetic diagnostics and increasing the clinical
usefulness of genetic information. These methods are based on existing approaches that use deep learning (DL)
to impute missing phenotype data. DL methods can leverage information about the context in which diagnoses
are seen to learn information about the relationships between diagnoses. This allows them to make accurate
predictions about even very rare diseases by analyzing the contexts in which specific diagnoses are seen. At the
same time, they can transform these raw data into biologically meaningful signatures, which can be extracted
and analyzed to gain insight about disease biology. We will develop and apply these methods in electronic
health record (EHR) data, metabolomics data, and proteomics data, using data from the UK Biobank, the NIH
All of Us program, the Mount Sinai BioMe Biobank, and the Mount Sinai Million Health Discoveries Program.
The result will be robust, validated, and clinically useful prediction methods for disease risk based on DL
phenotype imputation, as well as new insights into the biology and genetic architecture of rare genetic diseases.

Public health relevance
Project Narrative In this project, we aim to apply deep learning (DL) methods to electronic health records (EHR) and multi- omics data to predict risk of rare disease in individuals who harbor monogenic risk alleles. The resulting predictors will refine genotype-based prediction of disease risk, making genetic information much more clinically useful. Analyzing these predictors will also provide valuable insight into the biology and genetic architecture of rare disease.